WHICH DEPRESSIONS RESPOND TO COGNITIVE THERAPY?

Previous research has shown that cognitive therapy (CT) markedly reduces or eliminates symptoms in roughly 60% of outpatients with nonpsychotic, nonbipolar major depressive disorder (MDD). Prophylaxis may ensure in somewhere between 30 and 70% of CT responders in the year following treatment. Consistent predictors of the acute or prophylactic response to CT are not known. This competitive renewal is aimed first at completing our ongoing study (first 1-1/2 years) (Protocol I). This requires 80 outpatients with nonpsychotic, nonbipolar MDD diagnosed by SADS-L and RDC to complete 10 weeks (20 sessions) of individual CT. Pretreatment measures include symptom severity, history of illness and cognitive measures, as well as pretreatment polysomnographic (PSG) assessment (two consecutive nights) and the dexamethasone suppression test (DST). Two groups are formed based on pretreatment REM latency values. The main prediction is that those with reduced REM latency (<65.0 minutes) will not respond as well as to the acute phase of CT as those with nonreduced REM latency (>65.0 minutes). Other possible predictors of response (e.g., length of episode, length of illness, cognitive measures) are also evaluated. Whether symptomatic response is associated with cognitive or PSG changes is assessed. Responders to CT enter a 12- month post-treatment monthly follow-up which includes clinical and cognitive measures, PSG and DST. Predictors or relapse during this follow-up are sought. Protocol II is designed to assess the effect of 10 booster sessions over 8 months following the end of a 20 session CT package in reducing relapse. CT responders are randomly assigned to booster or no booster groups. One hundred and ten outpatients with MDD will enter CT, of which 60 will enter the booster and follow-up phases. Monthly follow-up during the 8-month booster/no booster phase, as well as for 12 months following the end of this phase is planned. Measures include symptomatic, cognitive, and life events. In addition the PGS is conducted every 2 months. Pre- and post- treatment predictors of relapse and of the effect of booster sessions are sought.